Grape Seed Extract Modulation of Peripheral and Central Nervous System Neuron-Glia Interactions

Principal Investigator: Durham, Paul Louis
Summary
Our long-term goal is to better understand the cellular and molecular changes in neuron-glia communication
mediated by a polyphenol-enriched grape seed extract (GSE) to reduce the burden of chronic pain. Based on
findings from our prior NIH grant, we discovered that dietary supplementation with the nutraceutical GSE
inhibits trigeminal pain signaling in preclinical models of temporomandibular joint disorder (TMD) and migraine.
The mechanism involved modulation of the serotonergic/GABAergic descending inhibitory pain pathway, which
is activated by endogenous opioids and endocannabinoids. The inhibitory effects of GSE on trigeminal pain
signaling involves activation of GABAB receptors in the spinal cord. GABAB receptors are expressed on the
central nervous system glial cells, astrocytes, and microglia, and on trigeminal ganglion satellite glial and
Schwann cells. GABAB are Gi/o protein-coupled receptors that decrease intracellular cAMP levels and inhibit
activation of the pro-inflammatory signaling enzyme protein kinase A (PKA), whose elevated expression is
implicated in the development of chronic pain. The chronic pain reported for TMD, and migraine is associated
with sustained peripheral and central sensitization and involves enhanced neuron-glia interactions. A
significant role for calcitonin-gene related peptide (CGRP) has been established in the underlying pathology of
chronic orofacial pain by enhancing neuron-glia communication in the trigeminal ganglia and spinal trigeminal
nucleus. The physiological effects of CGRP, which include promoting neurogenic inflammation and enhancing
pain signaling, are mediated via activation of CGRP receptors expressed on satellite glia, Schwann cells,
astrocytes, and microglia. CGRP binding to its receptor couples to the Gs protein, activation of adenylate
cyclase, increased cAMP levels, and enhanced PKA activity that promote cellular changes in peripheral and
central nervous system neurons and glial cells. CGRP also increases expression and activity of the pro-
inflammatory and pro-nociceptive enzymes inducible nitric oxide synthase (iNOS) and p38 MAP kinase in glial
cells. Recently, we published that GSE could suppress basal CGRP secretion, enhance neuronal expression
of the glutamate synthesizing enzymes GAD 65/67, and increase basal expression of GABAB in cultured
satellite glia and Schwann cells. In our proposed studies, we will test the hypothesis that GSE-mediated
increased expression of Gi/o-coupled GABAB receptors on glial cells will inhibit the stimulatory effects of Gs-
coupled CGRP receptors that are implicated in the development of peripheral and central sensitization and
chronic pain. Given the need for safer and more effective therapeutic options for managing chronic pain, we
will test if dietary inclusion of GSE can lower the concentration of the GABABR agonist baclofen (prescription
medicine) for inhibiting CGRP activation of glial cells. Hence, we want to validate whether combining a
nutraceutical with a pharmaceutical agent would provide a novel integrated strategy for managing chronic pain
by restoring and maintaining normal peripheral and central neuron and glia function within the nervous system.
1

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Durham, Paul, Louis NARRATIVE We have shown that dietary supplementation of a polyphenol-enriched grape seed extract inhibits expression of proteins implicated in chronic pain and enhances descending pain modulation pathways activated by opioids and cannabinoids. Our goal is to better understand the cellular and molecular changes within the nervous system mediated by grape seed extract to further validate its use as a safe and effective nutraceutical in a complementary and integrated therapeutic approach for chronic pain.